FATTY ACID KINETICS DURING EXERCISE ABOVE AND BELOW THE ANAEROBIC THRESHOLD

To determine whether FFA mobilization and utilization may limit exercise duration above or below the AT, and whether differences exist between highly trained and moderately trained endurance runners.